Leveraging social connection by including informal caregivers in an internet video conference-based compassion meditation intervention to reduce psychological distress in breast cancer survivors

ABSTRACT
Many breast cancer survivors (estimated 70% in some studies) experience clinically significant depression
and/or anxiety (together psychological distress, hereafter distress) in the months and years after finishing cancer
treatments. To address this important need, meditation interventions have been developed to reduce distress
for breast cancer survivors, while also improving (or stabilizing) objective indicators of stress physiology (i.e.,
diurnal cortisol rhythm; DCR). In the last several years, progress has been made to deliver these meditation
interventions through digital technology to improve scalability and accessibility (i.e., online and/or through apps)
to reduce distress experienced by survivors. Online meditation interventions are especially important because
they ensure ongoing viability of a popular integrative modality for many survivors who are unable to engage in
face-to-face supportive care activities outside the home. Despite progress, existing online meditation
interventions have several limitations that undercut their effectiveness to reduce survivor distress. Online
meditation interventions have: 1) centered mostly on mindfulness, which does not actively work to cultivate
prosocial and interpersonal relationship capacity and provides limited contemplative skills for survivors who may
suffer from feelings of social isolation that contribute to distress; 2) often been asynchronous, with no direct
interventionist contact over the course of meditation training; and 3) have often not included survivors' informal
caregivers (i.e., adult family members who live with and typically provide half the care for survivors). This
research will address these limitations. We will build on the rigor of prior research to reduce survivor distress
with a compassion meditation intervention called CBCT (Cognitively-Based Compassion Training) for online
synchronous delivery by trained interventionists that is also inclusive of caregivers. CBCT is an 8-week
intervention that starts with attention and mindfulness but then builds to contemplation about compassion for the
self and others, and is different from other meditation interventions (i.e., mindfulness meditation). The goal of
CBCT is to directly enhance feelings of social connection, equanimity, and self-compassion, and reduce negative
affect, and through these pathways lessen distress. We seek to determine if CBCT reduces distress and
improves DCR for survivors compared to an active attention control (Health Education, HE) when delivered
remotely by Zoom to both survivors and caregivers as a dyad (i.e., CBCT for dyads; CBCT-D). We will also test
whether or not including caregivers in CBCT-D reduces distress and optimizes DCR more than when survivors
receive CBCT by themselves alone (i.e., CBCT for survivors; CBCT-S). If successful, this research will provide
evidence regarding efficacy of an online, synchronous dyadic CBCT intervention and the extent to which it
does so through the mediational pathway of social connection with caregivers. This research will fill an important
gap in evidence for interventions that can reduce distress, an NCI priority for the growing numbers of survivors
and caregivers.

Public health relevance
Many breast cancer survivors (estimated 70% in some studies) experience clinically significant depression and/or anxiety in the months and years after finishing cancer treatments. This research will build on the rigor of prior research to reduce breast cancer survivor depression and anxiety with a compassion meditation intervention called CBCT (Cognitively-Based Compassion Training) for online synchronous delivery that is also inclusive of informal caregivers (i.e., adult family members who live with and typically provide half the care for survivors).